Multi-speed Ergonomic Wheelchair

The Minneapolis Adaptive Design & Engineering (MADE) Program has recently developed ergonomic
wheelchairs that use a chain drive system to place the hand rims in an ergonomic position while keeping
the rear drive wheels posterior for a stable base of support. Our ergonomic wheelchair’s forward hand
rim positioning allows for a more efficient push along a longer arc length of the hand rims, without
sacrificing wheelchair stability or shoulder ergonomics.
The ergonomic wheelchair’s chain drive allows for individualized gear ratios to suit each wheelchair
user’s needs; however, we have not yet studied this feature. Thus, the objectives of this proposed work
are to (1) explore the effect of different gearing options on Veteran wheelchair user steady-state
propulsion efficiency, and (2) develop a multi-speed ergonomic wheelchair allowing for lower gears
during difficult situations (initiating movements, moving over carpeting) and higher gears for steady-
state movements on flat surfaces.
We will recruit 18 Veterans with SCI/D to participate in a cross-over study of the ergonomic wheelchair
with three gear ratios (3:2 (low), 1:1 (normal), and 2:3 (high)). We will use two measurement
approaches to assess efficiency: (1) work done at the pushrim hubs to move the wheelchair in Joules
(J), and (2) the measurement of energy (kCal: kilocalories) expended by the Veteran to move the
wheelchair. Similar to miles per gallon in a car, we will calculate distances traveled in meters (m) per
energy units (m/J and m/kCal) as our measures of efficiency. We hypothesize that (H1) Higher gear
ratios will be more efficient (higher m/J) on hard level terrain than lower gear ratios, (H2) Lower gear
ratios will be more efficient (higher m/J) for inclined terrain than higher gear ratios, (H3) Lower gear
ratios will be more efficient (higher m/J) for carpeted terrain than higher gear ratios, and (H4) Veterans
will be more efficient (higher m/kCal) in moving the wheelchair during the 6MPT on hard level terrain
when using higher gear ratios compared with lower gear ratios. In addition to steady-state measures,
we will also explore the effects of gearing on propulsion initiation and expect lower gear ratios will be
beneficial for initiation on all terrains.
We will then recruit 12 Veterans to try a new multi-speed ergonomic wheelchair that has two hand rims
per side – one in a lower gear and the other in a higher gear. The proposed system does not require
manual or electric shifting between gears. Instead, the Veteran can use the lower gear to initiate
movements and then “shift on the fly” by simply pushing on the other hand rim. Veterans will return to
the laboratory and provide feedback as the design is iteratively improved. Quantitative and qualitative
data will be captured to determine feasibility of this approach and to promote commercialization of the
multi-speed ergonomic wheelchair.
Throughout the project, our team will work closely with VA’s Technology Transfer Program and the
TechLink Center to find an industry partner for this work. Our team has demonstrated the ability to
develop rehabilitation products into commercially licensed products. We will follow a similar stage-gate
process in this development project to maximize our chances for successful commercialization of the
modular multi-speed ergonomic wheelchair.

Public health relevance
Over one million Americans rely on their upper extremities for manual wheelchair propulsion. Shoulder overuse injuries are prevalent among manual wheelchair users and these injuries often result in shoulder pain. Severe shoulder pain can lead some wheelchair users to transition from manual to powered mobility, complicating transportation, and reducing independence in activities of daily living. This project will expand our understanding of a new wheelchair design that allows better positioning of the hand rims and allows for different gearing. We will study steady-state propulsion efficiency with different gear ratios and develop a new system with multiple gear ratios. The advanced gearing will allow for a low gear when initiating movement, going uphill, or when moving over carpet, and then a higher gear option for movements on hard flat level terrain. This system has the potential to dramatically improve shoulder ergonomics and reduce pain in many future manual wheelchair users.